Core A: Admin Core

ABSTRACT
The Administrative Core will manage the budgetary, administrative, and communication aspects of this Program.
The Core will be responsible for coordinating meetings and interactions among investigators, transmitting data,
communicating with NIH program personnel, preparing publications, and maintaining a bibliography describing
work performed, and all relative financial matters. As Administrative Core PI, Dr. Pierson will supervise the
interactions among the Project Leaders, ensure close communication among the Investigators, and assure
participation by the Project and Core leaders in the activities of the NIAID Xeno Consortium. The Program
Manager will act as a liaison with the hospital’s financial office, office of research affairs, and materials
management. The Administrative Core also includes a Program Statistician, who is available for consultation on
study design, calculation of sample size, and analysis of data from animal studies.